BIOCHEMICAL AND IMMUNOLOGIC MECHANISMS IN VIRALLY-INDUCED CNS DEMYELINATION

This project concerns mechanisms of demyelination in human disease and continues to focus on the human polyomavirus JC (JCV), the etiologic agent of progressive multifocal leukoencephalopathy (PML). PML is a fatal demyelinating disease which complicates about 5% of AIDS cases, and for which there has been no treatment known. Work this year has emphasized the detection of the virus by polymerase chain reaction (PCR) in PML tissues, in normal human brain tissues, in brain tumors, in human kidneys, in urine in infected hamster tissues, and in transgenic mice. (Parts of this work are reported under related projects in this Section.) We found that JCV DNA could be detected in 33 of 46 (72%) of sections from PML blocks. We have also found that JCV sequences could be detected in a paraffin section which had been scraped from slides following immunocytochemical staining. Detection of JCV in that biopsy tissue allowed confirmation of suspected PML which has been successfully treated with high dose AZT. This allows reexamination of large numbers of archival PML materials, even those which have already been utilized for conventional pathological studies. In a related project, two genotypes of JCV have been demonstrated following sequencing of a 610-bp fragment comprising the VP1 gene. This information has allowed design of type-specific primers which can also be applied to archival CNS tissues in paraffin. As these two types of JCV do not differ serologically, this approach is the only means to differentiate these JCV types, the clinical significance of which is currently unknown. This work has demonstrated that PCR is a powerful technique to detect JCV DNA sequences in sections from CNS paraffin blocks-allowing confirmation of diagnosis with great sensitivity, allowing distinction from SV40 DNA sequences with virus-specific primers, and allowing typing of JCV DNA as JCV-1 or JCV-2. In collaboration with a laboratory at Penn State university, JCV DNA sequences have also been demonstrated in frozen tissues from non-PML brains without evidence of demyelination or other pathology. This finding suggests that some cases of PM L may represent the reactivation of JCV which was already latent in the brain prior to the acquisition of HIV infection or another immunosuppressive condition.